GENETIC BASIS OF FAMILIAL NEUROGENIC DIABETES INSIPIDUS

The aim of this project is to determine whether an inherited disease known as familial neurogenic diabetes insipidus (FNDI) is caused by a mutation in a gene that codes for the antidiuretic hormone, arginine vasopressin (AVP).